CHIME Community Liaison and Recruitment Core (CLRC)

Project Summary for the RCMAR CHIME Community Liaison and Recruitment Core
For the past 20 years, our CHIME Scientists and faculty have worked in partnership with local community
leaders in aging on community-based projects aimed at mitigating health disparities for minority elders. With
this application we propose to renew our Community Liaison Recruitment Core (CLRC) and to expand its
reach throughout Los Angeles County and into Riverside County. By supporting RCMAR Scientists in
conducting high-quality, cutting- edge research in priority areas of aging-relevant behavioral and social
science, the CLRC is intended to support our Center theme of “Developing, Adapting and Evaluating
Interventions to Improve the Health of Minority Elders,” which incorporates elements of two of the RFA
research objectives: i) identify and develop solutions to eliminate health disparities and health inequities in the
growing population of older adults, and ii) improve the health and well-being of older adults. The three Specific
Aims of the CLRC are to: 1) Facilitate recruitment and retention of minority seniors for CHIME-supported
academic-community partnered research projects, 2) Generate new knowledge of techniques for recruitment
and retention of minority seniors, and 3) Disseminate the most effective techniques and research advances
that are most relevant to our community partners to both the scientific and lay communities. The CLRC works
closely with an established Community Action Board (CAB) that includes 19 ethnically diverse members, who
support the Center theme through their involvement in the selection and co-mentorship of RCMAR Scientists in
their projects, participation in the research, scientific retreats, and other administrative tasks. The CLRC will
also continue to facilitate recruitment of minority elders for research projects addressing the Center theme
through the successful approach of training bilingual, bicultural undergraduate students at UCLA and UC
Riverside, our new HSI partner institution, and MPH students at Charles R. Drew University (CDU) to recruit
and enroll research subjects in the community. This assistance will be available for recruitment for all pilot
studies. Finally, the CLRC will continue to disseminate research findings through the academic networks of our
affiliated centers as well as to the lay community.